Integration of non-invasive deep tissue microwave thermometry in the VectRx hyperthermia device in a transgenic liver tumor pig model

Project Summary/Abstract
NeoTherma Oncology (NTO/www.neothermaoncology.com) has developed a novel non-invasive medical device
that delivers mild hyperthermia (HT) loco-regionally as adjuvant therapy to standard of care treatment of
abdominal deep-seated tumors. The VectRx™ device, designated “Breakthrough” by the FDA, has
demonstrated its ability to safely heat abdominal organs (pancreas, liver, kidney, spleen) in pre-clinical studies
in healthy swine. FDA approved an investigational device exemption for VectRx on the basis of these data and
the lack of a validated large animal tumor model for pancreatic cancer. NTO has initiated a First in Human early
feasibility study (EFS) study at the University of Maryland Medical Center to collect initial safety and performance
data in pancreatic cancer patients.
In parallel to the EFS, NTO will collaborate with University of Colorado-Boulder researchers who have developed
a microwave thermometer (MT) that could be utilized to non-invasively measure temperatures in deep tissue.
This development is based on the ability to detect the black body radiation proportional to temperature that is
emitted at different tissue depths from skin to deep organ. Successful integration of the MTs will effectively
improve the clinical utility of VectRx. This will address challenges posed by the limited availability, access, high
cost, logistical concerns and reliance on specialized personnel, as is the case with magnetic resonance
thermometry. A series of MTs and a radiometer will be designed, fabricated, and integrated into VectRx with
potential VectRx coil adjustments to 1) achieve compatible designs of active and passive MTs with operation
within VectRx (on and off); 2) manage any potential heating of the MTs, coil detuning, E-field and H-field pattern
integrity during VectRx operation. Following co-development and optimization, the MTs’s performance will be
established in a hepatocellular carcinoma (HCC) Oncopig model with an accuracy goal of 1.5°C. HCC is a
disease with low survival rates and only a small fraction (15%) of newly diagnosed patients are eligible for
curative treatments due to late diagnosis. The model is relevant to NTO’s indication pipeline of deep-seated
abdominal tumors, and NTO has previously completed installation of the VectRx device and performed
preliminary work in 3 HCC Oncopigs with the veterinary team at the University of Illinois to optimize ultrasound-
guided surgical placement of fiberoptic probes that will be used to correlate temperatures measured by the MTs.
Despite the known benefits of mild HT, it has not been widely adopted in the US because of the technical
limitations of current technologies to address deep, hard to heat tumors and the lack of thermometry. In this
Phase I project, we will demonstrate that these critical deficiencies can be overcome through integration of novel
microwave-based temperature techniques with VectRx, providing an innovative demonstration of advanced
temperature monitoring of HT in deep tissue in a large animal tumor model.

Public health relevance
Project Narrative Clinical trials show that hyperthermia sensitizes tumors to standard chemotherapy and radiation treatments and improves patient outcomes, but adoption in the US has lagged due to inadequate devices and the inability to measure tissue temperature to ensure safety and effectiveness. In this proposal, NTO and the University of Colorado-Boulder will co-develop and validate in a pig model a microwave thermometer customized for operation with VectRx, a device NeoTherma Oncology (NTO) has developed to safely heat deep solid tumors. Success in this study will provide NTO with a practical, low-cost non-invasive pathway to measure temperature in deep tissue with microwave thermometers.